DIVISION OF CANCER CONTROL AND POPULATION SCIENCES (DCCPS) BIOMEDICAL COMPUTING SUPPORT SERVICES_ Moonshot Support

The Division of Cancer Control and Population Sciences (DCCPS) of the National Cancer Institute (NCI) generates new knowledge about the burden of cancer on the US population and seeks to develop strategies in the continuum of cancer care including prevention, diagnosis, treatment and survivorship strategies. DCCPS also houses the Surveillance, Epidemiology, and End Results (SEER). The National Cancer Act of 1971 authorizes collection of cancer registry data and mandates that NCI report population-based statistics.

The objective of this Task Order (TO) is to obtain non-research and development (non-R&D), information technology and analytic services to the DCCPS, NCI. These services occur across several broad areas such as: analytical support, systems development, data management and maintenance, computing infrastructure maintenance and support, statistical methodology and programming support, and support developing and maintaining websites.